Zika virus pathophysiology during pregnancy

Overall - Project Summary/Abstract
A surge in birth defects accompanied the arrival of Zika virus (ZIKV) in the Americas. As ZIKV spreads
explosively in populations with no pre-existing immunity, an entire generation of pregnant women and
their babies may be at risk for congenital Zika syndrome. Unfortunately, nearly nothing is known about
the parameters impacting fetal risk during pregnancy—and epidemiological studies following large co-
horts of pregnant women will take years.
We developed the first nonhuman primate model for studying the impact of ZIKV infection during preg-
nancy. The most provocative initial finding from these studies is that maternal viremia persists for weeks
to months in pregnant macaques, in contrast to viremia that lasts only 7-10 days in non-pregnant ma-
caques. The key hypothesis of this Program Project is that prolonged maternal viremia during
pregnancy predicts fetal risk of congenital Zika syndrome. A corollary is that duration of sustained
viremia can be used to assess the impact of co-factors and interventions that modulate the risk of con-
genital Zika syndrome. We will explore this hypothesis through three integrated projects:
Project 1. Define the impact of sustained ZIKV viremia in pregnancy on neonatal outcomes. We will
assess the relationship among prolonged viremia, vertical transmission, and neonatal injury.
Project 2. Assess whether pre-existing immunity to dengue virus, elicited by infection or vaccination
with a licensed vaccine, increases the likelihood or duration of sustained ZIKV viremia in pregnancy.
Project 3. Evaluate whether passive administration of ZIKV-specific antibodies can prevent acquisi-
tion and/or reduce the severity of ZIKV when administered therapeutically.
ZIKV is dangerous to pregnant women and their fetuses/neonates throughout the Americas. This risk
will persist for at least several years, even if it is eventually curtailed by natural immunity and widespread
vaccination. This Program Project will provide important new tools for pregnant women and their health-
care providers to assess, and potentially reduce, the risk of congenital Zika syndrome.

Public health relevance
Overall - Project Narrative Zika virus infection during pregnancy can cause multi-system (e.g,. brain, retinal, auditory, musculo- skeletal, placental) fetal damage of varying severity, effects that are collectively termed congenital Zika syndrome. In this Program Project we will test the hypothesis that prolonged detection of Zika virus in maternal blood during pregnancy predicts fetal injury and birth defects, both of which we predict are more common than currently thought. We will also evaluate how pre-existing immunity to related den- gue viruses and passive immunity to Zika virus modulate the duration of sustained Zika virus detection and/or risk of congenital Zika syndrome in fetuses; completion of this project could provide pregnant women with a better way of assessing the risk of congenital Zika virus infection and offer new therapeu- tic options to reduce this risk during the later stages of pregnancy.